Columbia Population Research Center - Computing and Methods Core

Computing and Methods Core – Abstract
The computing and methods core (CMC), led by Julien Teitler (Social Work), Thomas DiPrete (Arts &
Sciences), and Andrew Rundle (Public Health) achieves CPRC aims by providing computing and methods
services that enhance the quality of CPRC affiliates’ scholarship as well as their productivity and efficiency,
with a particular focus on supporting the research of junior scientists. These services, which have transformed
the computing and methods infrastructure at Columbia, include: 1) institutional leadership to advance the
university’s IT infrastructure and promote cross-institutional collaboration; 2) high performance computing; 3)
secure data analysis environments; 4) specialized desktop support; 5) GIS consulting service; 6) information
and training on innovative methods for data analysis; 7) a survey lab; and 8) support for data acquisition,
access, and sharing.